A new dimension to the olfactory system: long non-coding (lnc)RNAs and a lncRNA-encoded micropeptide

PROJECT SUMMARY
Olfaction plays a critical role in animal survival, enabling the detection of food sources, dangers, and potential
mates. The remarkable plasticity of the olfactory system allows for the modification of responses to cues based
on various internal states. However, the precise mechanisms underlying olfactory plasticity, particularly at the
level of peripheral sensory neuronal activity, remain poorly understood. In this research proposal, we aim to
investigate the contribution of long non-coding RNAs (lncRNAs) and lncRNA-encoded micropeptides in
modulating olfactory receptor neurons (ORNs) and other olfactory functions.
LncRNAs are transcripts longer than 200 nucleotides that lack an open reading frame longer than 100
codons. Various lncRNAs have been implicated in neural development, function, and diseases. While lncRNAs
are traditionally considered non-coding, certain lncRNAs encode micropeptides, which contribute to diverse
biological processes. Despite their abundance and potential importance, the functions of lncRNAs and their
encoded micropeptides in the nervous system, particularly in olfaction, remain largely unexplored.
To address this knowledge gap, we will capitalize on the well-characterized olfactory system of the fruit
fly. This system offers several advantages, including numerical simplicity, well-defined neurons that drive
complex behaviors, and the availability of powerful genetic tools. We recently generated a comprehensive survey
of lncRNAs in the main fly olfactory organ that demonstrated the diversity and expression patterns of lncRNAs
in the olfactory system and set the stage for investigating their functional roles and their impact on sensory
behaviors.
Through a multidisciplinary approach that includes genetic, electrophysiological, behavioral, and
molecular assays, we will test the hypothesis that lncRNAs and their micropeptides contribute to olfactory
modulation and function. Our initial focus will be on the lncRNA ANRUS (Antennal RNA Upregulated by
Starvation) and its encoded micropeptide. We will functionally characterize ANRUS and test whether it
contributes to olfactory modulation. During the R00 phase, we will investigate the unexpected regulation of
ANRUS levels by a food odor, ethyl acetate. Finally, we propose to expand our investigation by characterizing
the micropeptidome of the antenna, a first step toward exploring the regulatory roles of these micropeptides in
olfaction and gaining a deeper understanding of the mechanisms governing olfactory plasticity and function.
Dr. Talross will benefit from outstanding support from her mentoring team at Yale University, which will
facilitate her journey towards independence. The proposed objectives in this proposal are carefully designed to
equip Dr. Talross with the necessary skills and experience to secure an Assistant Professor position and pursue
R01 funding as an independent investigator.

Public health relevance
PROJECT NARRATIVE Insects can be detrimental to human populations due to the transmission of a variety of diseases and agricultural destruction. Chemosensory systems are critical for the effectiveness of these insects; olfaction is particularly important for navigating through the environment and finding human hosts and food. This project is designed to understand the molecular mechanisms by which these systems operate and could lead to new methods of controlling these insects and their impact on humans.